Implications of metabolism on healthy aging in African and Caucasian Americans: the Health ABC study

Project Summary
Over 100 million Americans will be over age 65 years by 2060 (representing 25% of the U.S. population), with
an increasing proportion of African-Americans. Understanding which Americans exhibit “exceptionally healthy
aging”—an older life free of illness, disability, or functional limitation—is central to efforts to improve quality of
life and resource utilization. Current investigations on “healthy aging” focus on systemic inflammatory markers
(e.g., interleukin-6) or composite indices of organ/metabolic function (the “healthy aging index,” HAI), both lim-
ited by a (1) lack of sensitivity for early changes in metabolism; (2) lack of specificity for molecular pathways
involved in these changes; (3) absence of investigation early in adulthood (when “aging” may be reversible);
(4) few studies of African-Americans, at high-risk for age-related morbidity. In preparation for this application,
we applied metabolite profiling in a pilot study of nearly 300 African-American males in Health ABC, a biracial
NIA study of elderly Caucasians and African-Americans, identifying metabolites associated with HAI (oxidative
stress, nitric oxide signaling, gut microbial metabolism), some of which may be unique to African-Americans.
Here, we hypothesize that circulating metabolites associated with multi-dimensional aging phenotypes and
outcomes in older adults will define pathways of “exceptional healthy aging” that may be race-specific and
dysregulated in youth at risk for “premature” aging. To address this hypothesis, we will harness two well-
characterized, biracial American cohorts that span life (elderly: age 73±3 N=1312; young: CARDIA, age 32±4
N=2376; R01-HL136541). In Aim 1, we define metabolic pathways implicated in race-specific healthy aging,
based on association between metabolites and validated age-related phenotypes heterogeneous by race
(physical, neurocognitive function, vascular structure, body composition). We will assess determinants of iden-
tified pathways, including dietary quality, physical activity, and psychosocial stress (poorer in African-
Americans). In Aim 2, we identify metabolites related to “exceptionally healthy aging” in the elderly (freedom
from disability, dementia, cancer, cardiovascular disease), their pathways, race-specificity, and overlap with
pathways identified in Aim 1. In Aim 3, we apply machine-learning techniques to metabolites to derive a classi-
fier for exceptionally healthy aging in Health ABC and apply this prediction rule to young adults in CARDIA to
identify young adults at risk for unhealthy aging. We then investigate whether individuals marked for premature
aging develop adverse aging phenotypes decades later (neurocognitive, physical, vascular, clinical outcome).
This proposal addresses a core mission of the NIA (directly responsive to PA-17-088) by defining a metabolic
basis for “exceptional healthy aging” across race and at the extremes of life. We leverage rich phenotypes
within Health ABC, funded efforts within CARDIA, and a team experienced in aging epidemiology, metabolic
research, and data science approaches. Successful completion of this project will furnish a rich molecular phe-
notypic resource to the aging community for investigation of mechanisms and biomarkers of biological aging.

Public health relevance
Project Narrative Nearly 100 million Americans will be >65 years by 2060. Current clinical-biochemical metrics of aging do not capture accelerated aging, specifically the clinical observation that African Americans are at especially high risk of age-related morbidity. Here, we perform metabolite profiling in the Health ABC study to identify metabolic pathways central to healthy aging across race and examine these pathways in a separate longitudinal study of young adults (CARDIA), redefining aging as a systemic metabolic disease impacting function and outcomes in Caucasian and African-Americans across life.